Administrative Core

Project Summary/Abstract: Administrative Core
The Administrative Core of the Washington University Chronic Kidney Disease National Resource Center will
provide the infrastructure of the overall Center. Benjamin Humphreys, M.D., P.D., is the Core Director and
Monica Chang-Panesso, M.D., is the Associate Director responsible for the leadership of the Center, which will
consist of two Biomedical Resource Cores, the Variant Validation Core and Metabolism Core, and a Resource
Development Core, the Single Cell Omics Research Evolution Core (SCORE Core). The Administrative Core
will communicate with the National O’Brien Consortium to prioritize external requests and distribute resources
efficiently. They will plan and execute a Summer Student Enrichment Program focused on medical students,
facilitate outreach efforts locally and nationally, and promote a culture of diversity and inclusion. They will
support cost recovery efforts for the two Biomedical Resource Cores and lead efforts to attract early-stage
investigators to kidney research. The Administrative Core will work closely with an Internal Advisory Board, led
by Victoria Fraser, M.D., the O’Brien Centers Steering Committee, and external Consortium Management
Board to ensure that the activities of the Washington University Chronic Kidney Disease National Resource
Center are aligned with the objectives of the national network of O’Brien National Resource Centers.